New Hampshire Food Emergency Response Network Laboratory Flexible Funding Model

OVERALL
PROJECT SUMMARY/ABSTRACT
During the 2025-2030 period, New Hampshire Public Health Laboratories (NH PHL) intends to maintain and
enhance the capabilities of human and animal food testing laboratories in support of an integrated food safety
system (IFSS). This objective will be accomplished through prioritized sample testing and food defense
preparedness, with guidance from FDA LFFM. The multicomponent grant with fifteen projects will strengthen
and improve NH PHL’s efforts to prevent foodborne illnesses and minimize foodborne exposures by supporting
a nationally integrated network, and equipping NH PHL to serve as a resource capable of increasing sample
throughput capacity within the state and nationally.
NH PHL proposes a total of 15 projects comprised of the following:
Discipline A: Microbiology
Track A1: Human Food Product Testing (500 analyses)
Track A2: NARMS Product Testing (150 analyses)
Track A3: Animal Food Product Testing (100 analyses)
Track A4: Whole Genome Sequencing – Maintenance
Track A6: Food Defense
Track A7: Method Development/Validation
Track A8: Capacity/Capability Development
Discipline B: Chemistry
Track B1: Human Food Product Testing (500 analyses)
Track B2: Animal Food Product Testing (100 analyses)
Track B3: Food Defense
Track B4: Method Development/Validation
Track B5: Capacity/Capability Development
Discipline C: Radiochemistry
Track C1: Food Defense
Track C2: Method Development/Validation
Track C3: Capacity/Capability Development

Public health relevance
OVERALL PROJECT NARRATIVE This cooperative agreement will enhance the capacity and capabilities of the New Hampshire Public Health Laboratories (NH PHL) to collect and conduct food testing for pathogens, chemical contaminants, and radiochemical hazards, in support of a nationally integrated food safety system. Human and animal product testing of microbiological and chemical contaminants will be conducted using existing methods, in which NH PHL is accredited by ISO-IEC 17025-2017, and novel methods will be developed and expanded to enhance analytical capabilities in food testing in collaboration with FDA and the Food Emergency Response Network (FERN). This will help NH PHL assist FDA in facilitating a more rapid response to foodborne disease outbreaks.